Electronic Tools to Increase Recognition and Improve Primary Care Management for Hypertension in Chronic Kidney Disease: A Multi-site Randomized Clinical Trial

ABSTRACT
Chronic kidney disease (CKD) affects 1 in 7 adults in the United States. Despite its high
prevalence, approximately 90% of those with kidney disease are not aware they have it. In
addition, hypertension (HTN) remains a leading cause of end stage renal disease and greatly
impacts the risk for adverse cardiovascular outcomes in the CKD population. Primary care
physicians (PCPs) are uniquely positioned to effectively manage CKD through early
identification and use of evidence-based treatments, but they face time-constraints and
competing demands. Clinical decision support (CDS) tools can bridge that gap by utilizing data
within the electronic health record (EHR) to provide recommendations. In our prior work, we
incorporated behavioral economic principles and human-centered design in a CDS tool to
deliver tailored, actionable, and evidence-based recommendations for the management of HTN
within a primary care CKD population. We demonstrated that the CDS had a statistically
significant effect on lowering systolic blood pressure (SBP), in addition to increasing prescription
for evidence-based renin-angiotensin-aldosterone system inhibitor (RAASi) therapy. In this
project, we aim to establish the generalizability of these findings by implementing the CDS tool
across three health systems. We will also update the CDS to address medication nonadherence
and to incorporate new clinical practice recommendations for sodium glucose co-transporter-2
inhibitors (SGLT2i). The specific aims of this project are to 1) adapt and pilot test CKD CDS in
multiple health systems, 2) determine the effectiveness of the CDS alerts on lowering SBP and
increasing RAASi/SGLT2i prescriptions in a pragmatic randomized trial in 36 primary care
clinics across three health systems and 3) use two implementation frameworks, TAM3 and
Proctor’s Implementation Outcomes Framework, to assess implementation outcomes and
factors influencing implementation in order to inform further dissemination. In summary, this
renewal application seeks to establish the scalability of a CDS tool, based on behavioral nudge
alerts, across diverse patient populations and various EHR workflows for the management of
HTN in adults with CKD within primary care settings.

Public health relevance
Chronic kidney disease (CKD) and uncontrolled blood pressure , the main risk factor for CKD progression, are not diƯicult to diagnose, but both often go unrecognized by primary care physicians (PCPs). Computerized tools may help PCPs to diagnose the disease earlier and computerized tools may help doctors to prescribe the best treatments for high blood pressure which will prevent dialysis and heart problems. In this project we will evaluate computerized tools, previously tested at BWH, at multiple clinics in three health systems in Boston, New York City, and Madison, Wisconsin in a pragmatic cluster randomized trial.